NEVIRAPINE, LAMIVUDINE AND BACKGROUND NUCLEOSIDE THERAPY IN AIDS

The objective of this study is to evaluate the tolerance, safety, and effectivenss of Viramune (nevirapine) in preventing clinical AIDS progression events or death when used in combination with lamivudine and background nucleoside therapy.